Deciphering the role of eIF5A in mitochondrial function

Project Summary/Abstract
The eukaryotic initiation factor 5A (eIF5A) is a conserved translation factor that is important for the
resolution of certain ribosome stalls. eIF5A has been found to be integral for mitochondrial function
from yeast to mammalian cells. Despite its recognized importance across species, the precise
molecular mechanism by which eIF5A influences mitochondria is not fully understood. This gap in
knowledge is especially pertinent given the established links between mitochondrial dysfunction and a
range of diseases, including neurodegenerative disorders and cancer.
The central objective of this project is to elucidate the mechanisms through which eIF5A depletion
affects mitochondrial function, hypothesizing that such depletion leads to ribosome stalling on
mitoproteins during co-translational import. This stalling is thought to trigger a mitochondrial import
stress response, influencing the translation of various mitochondrial proteins and, consequently, the
overall cellular health and function. By integrating gene expression reporters with advanced
methodologies such as fluorescent microscopy, proteomics, CRISPR library screening, and Cryo-
Electron Tomography, this research promises to offer comprehensive insights into eIF5A's role in
mitochondrial health and dysfunction. The outcomes are expected to not only deepen our
understanding of fundamental mitochondrial biology but also highlight potential therapeutic avenues for
tackling diseases associated with mitochondrial dysfunction.

Public health relevance
Project Narrative Mitochondrial dysfunction is proposed to be a contributing factor to a number of diseases such as obesity, cardiovascular diseases, cancer, diabetes, and many types of neurodegeneration. The proposed research will explore the mechanism by which mitochondrial function is modulated by the conserved translation factor eukaryotic initiation factor 5A (eIF5A). In the long term this research may give us greater understanding to combat mitochondrial dysfunction during disease.